SYMPOSIUM--'NEW DIRECTIONS IN PRIMATE REPRODUCTION'

Tremendous strides have been made in the are of primate reproductive biology, particularly over the past 10 years, much of which have been influenced by advances in human in-vitro fertilization, and other "assisted technologies." Although, rarely, are Symposia given on selected aspects of these topics, a common forum for their presentation has not been found; due primarily to the diversity and disparity of the elements involved. This Symposium will focus upon the latest developments in the field of non-human primate reproductive biology, and will emphasize biomedical modeling, and recent technologic advances in a few primate species, all within the framework of ontogenic progression from follicle/oocyte maturation to implantation of the embryo. The general areas to be addressed will be: (1) regulation of ovarian follicle development and follicular imaging; (2) primate in-vitro fertilization; and (3) embryonic development and implantation. Emphasis will be given to applying the most recent cellular and molecular techniques to the sequence from follicular ripening to embryonic implantation and development--approaches that can not be emulated in humans. This Symposium will therefore serve to further elucidate complicated aspects of primate reproduction; and will thereby contribute uniquely to the field of primatology in general.